MOLECULAR ANALYSIS OF MUTATIONS IN DUCHENNE AND BECKER MUSCULAR DYSTROPHY

The goal of this protocol is the description of mutations in patients with Duchenne Muscular Dystrophy and Becker Muscular Dystrophy on the DNA level and to correlate the analysis of mutations with clinical findings.